Admin Core

PROJECT SUMMARY/ABSTRACT
The proposed Administrative Core is designed to ensure efficient day-to-day operation of our proposed UCLA
Institutional Kidney, Urology and Hematology Advanced Research Training Program (KUH-ART). Our Multiple
PIs (MPIs) have together compiled exemplary records over the past several decades of managing productive
collaborative research programs and of educating and training outstanding young KUH scholars, including the
initial 5-year funding period of the NIDDK T32 Translational Research Training in Pediatric Nephrology
(5T32DK104687-05). Our leadership structure, patterned on that of the successful UCLA CTSI, that includes
four different institutions– UCLA, Cedars-Sinai Medical Center, Charles Drew University of Medicine and
Science, and Harbor-UCLA Medical Center/Lundquist Institute located in the LA metropolitan area. Each of our
partner institutions is well represented in leadership to facilitate communication and collaboration among our
cores and institutional sites. In order to carry out the different KUH-ART initiatives, the Administrative Core will
have the following specific aims (1) Establish the organization and governance to support integration of KUH
expertise and resources across our partner institutions and to coordinate with the national network. (2) Support
strong communication between trainees, mentors, our cores, and sites as well as with the national network to
create a highly productive, collaborative environment. (3) Devise and implement a comprehensive tracking and
ongoing evaluation to identify weaknesses and institute continuous quality improvement. The evaluation
approach evaluation team will design and implement a novel and comprehensive tracking and continuous
process improvement approach. This Administrative Core will create the appropriate academic environment that
will enable the development of the KUH research skills and experience needed for successful, independent
scientific careers as members and leaders of interdisciplinary teams dedicated to improving KUH patient and
population outcomes.